Behavioral and neural mechanisms of active word learning in child-caregiver interactions

Project Summary
Caregiver-child dyadic interactions are central to early word learning and set the trajectory for later language
development1,2. Past research typically focuses solely on parents’ role in determining the quality of early word
learning experiences, leading to parent-focused interventions aimed at improving early language experiences3,4.
However, these approaches often neglect that children are active, curious information-seekers who contribute
substantially to structuring their own learning environment5,6. Understanding the behavioral and neural
mechanisms of how children’s early learning curriculum is mutually negotiated in dyadic child-caregiver
interactions may be key to predicting and reducing disparities in long-term language outcomes.
The goal of the planned research is to understand how both caregiver scaffolding and children’s active
information-seeking mutually contribute to effective word learning curricula. Central to this goal will be the
evaluation of caregiver-child interactions in families spanning the full spectrum of socioeconomic status (SES).
We will quantify variability in the dynamic negotiation of learning events between children and caregivers using
multiple methods, including novel brain-to-behavior coupling methods and naturalistic observation, in order to
trace early sources of individual differences in learning outcomes and word learning disparities. In Aim 1, we
develop an experimental paradigm to test our hypothesis that word learning is most successful when caregivers
and children jointly shape the learning input. In Aim 2, following technological advances in the Princeton Baby
Lab, we investigate the neural mechanisms underlying successful dyadic structuring of the learning input by
measuring dual-brain coupling between caregivers and children during word learning with functional near-
infrared spectroscopy (fNIRS). In Aim 3, we quantify patterns of coordinated information structuring by children
and caregivers during natural interactions in order to understand the ecological validity of the causal mechanisms
tested in Aims 1 and 2. Together, this research will provide insight into behavioral and neural mechanisms that
promote effective word learning curricula in dyadic child-caregiver learning events, with the ultimate goal of
improving word learning and language development across the SES spectrum.
Through these aims, the applicant will gain training in dual-brain neuroscientific techniques, broaden his
theoretical training in language and cognitive development, and gain experience working with diverse
populations and backgrounds, including across a wide SES spectrum. The sponsor, Dr. Casey Lew-Williams,
has extensive experience providing mentorship in all of these training areas. The co-sponsor, Dr. Uri Hasson, is
an expert in the study of neural coupling in dyadic interactions. The unique training environment at Princeton
University provides the resources necessary to successfully complete the proposed work, as well as additional
opportunities for mentorship and professional development. In sum, this project will provide the applicant with
training that will support his career goal of becoming a tenure-track professor at a research university.

Public health relevance
Project Narrative The goal of the project is to understand how both caregiver scaffolding and children’s active information- seeking mutually contribute to effective word learning by (1) testing a novel experimental paradigm that allows children and caregivers to control learning input, (2) measuring neural synchrony between children and caregivers during word learning, and (3) investigating information-structuring activities across child-caregiver dyads in naturalistic word learning contexts. We will quantify variability in the dynamic negotiation of learning events between children and caregivers in families spanning the full spectrum of socioeconomic status (SES), to trace early sources of individual differences in learning outcomes and word learning disparities. The results will provide insight into behavioral and neural mechanisms that promote effective word learning curricula in interactive child-caregiver learning events, with the ultimate goal of improving word learning and language development across the SES spectrum.